Novel light source development for robust multi-MHz retinal OCT

PROJECT SUMMARY / ABSTRACT
Ocular disease may arise anywhere in the human retina, which spans roughly 70% of the eye's
internal surface. While optical coherence tomography (OCT) has become the premier
technology for retinal disease diagnosis, current instruments are incapable of accessing the
peripheral retina due to slow imaging speeds. This proposal seeks to enable next-generation
OCT technology that will make diagnostic screening and visualization of both the central and
peripheral retinal areas a reality; increasing imaging speed roughly 50-fold will allow wide-ﬁeld
retinal imaging without increasing procedure time. This advancement is empowered by a novel
laser technology, stretched-pulse-mode-locking, recently developed for OCT by the founders
of Bluebird Photonics. This Phase I STTR support will allow Bluebird to reﬁne the SPML laser
design and advance from a prototype to a turn-key, environmentally robust commercial laser.
Speciﬁc aims include the implementation of a bias-free, Sagnac-loop amplitude modulator and
the development of a closed-loop locking mechanism to ensure a stable synchronization
between the modulator and the optical cavity resonance. The resulting laser will oﬀer a
signiﬁcant advance over existing commercial OCT technology in speed (5 MHz vs ~100 kHz),
cost, stability, reliability, and ease of integration. Commercial SPML lasers will serve as a
catalyst for further development of ultrawide-ﬁeld OCT instrumentation and support clinical
evaluation across a range of diseases.

Public health relevance
PROJECT NARRATIVE The proposed research and development activities address a pressing need for higher speed, wide-ﬁeld retinal imaging technology for the early diagnosis of ocular disease. Optical coherence tomography (OCT), already an established tool for ophthalmologists, is incapable of visualizing the entire retina fast enough to avoid motion artifacts; the successful development of the proposed laser technology will enable a ~50-fold increase in imaging speed in next- generation OCT.